CATCH Healthy Smiles: A cluster-RCT of an elementary school oral health intervention

ABSTRACT
This proposal responds to the NIDCR Behavioral and Social Intervention Clinical Trial Planning & Implementation
Cooperative Agreement (UG3/UH3). Our goal is to clinically evaluate the effects of a school-based behavioral
intervention to reduce the risk of dental caries in a cohort of kindergarten through 2nd grade (K-2) children.
Coordinated Approach to Child Health (CATCH) is an evidence-based coordinated school health program, and
has undergone several cluster-randomized controlled trials (CRCT) demonstrating sustainable long-term
effectiveness in improving eating and physical activity behaviors, and reductions in obesity prevalence among
low-income, diverse children. As part of our recent 12-month R34 grant (R34DE026245), we integrated oral
health lessons and activities into the existing K-2 CATCH program. The new program, called CATCH Healthy
Smiles, was successfully tested for feasibility with K, 1st and 2nd grade children in two low income Houston
elementary schools. Of the 113 children with dental assessments, 54% of children in Kindergarten, 62% in grade
1 and 73% in grade 2 had caries experience defined by any untreated caries or at least one filled deciduous or
permanent teeth. These results, and those of prior studies, warrant the need for evidence-based school health
curricula for oral health promotion. Our primary aims are: 1) In the UG3 one-year planning period (2019-2020),
our primary aim is to finalize measurement protocols, study databases, CATCH Healthy Smiles intervention
content and delivery framework, school and staff training, and recruit schools for a 26 school cluster-RCT
(CRCT). 2) In Years 2-6 (UH3, 2020-2025), our primary aim is to conduct a school-based CRCT to determine
the efficacy of CATCH Healthy Smiles in reducing the incidence and progression of dental caries as measured
at the tooth (d2,3mft/D2,3MFT) and tooth surface level (d2,3mfs/D2,3MFS) among children starting in
kindergarten and following through 2nd grade enrolled across 26 schools serving low-income, ethnically-diverse
children. We hypothesize that, at 3-year follow up (end of 2nd grade), as compared to children in the control
schools (n=13 schools; 533 children), those in the intervention schools receiving CATCH Health Smiles (n=13
schools; 533 children) will demonstrate significantly reduced incidence and progression of dental caries. Process
evaluation data will be collected throughout to monitor intervention dosage, reach and fidelity. Our secondary
aims are, 1) to quantify the impact of CATCH Healthy Smiles on child behavioral, psychosocial and
environmental outcomes, including child oral health behaviors, diet, and school nutrition environment, and 2) to
examine the extent to which these child behavioral, psychosocial and environmental factors (tooth brushing, diet,
oral health related quality of life) mediate the intervention effects on child caries risk. The suite of CATCH pre-K
to high school programs are licensed by UTHealth to a public charity, the CATCH Global Foundation. This project
is significant because if found to be effective, a platform for scalability, sustainability and dissemination of CATCH
already exists, and opens a new line of research in school oral health.

Public health relevance
Project Narrative Poor oral health is epidemic among American youth from low income families. School-based educational programs can be a venue for addressing this problem, however they have not been rigorously evaluated and documented as effective. This grant will allow us to plan for, and test the efficacy of an elementary school-based oral health intervention using a cluster-randomized controlled trial design across children from ethnically-diverse, low-income families in Houston, Texas.